Muscle metabolism, metabolic modulators and disabling exercise intolerance in the daily life of patients with heart failure and preserved ejection fraction

Heart failure with preserved ejection fraction (HFpEF) is the fastest growing form of heart failure, and is
characterized by severe exercise intolerance (EI), exertional fatigue, disability-associated reduced quality of life,
and increased mortality. The cause of the severe EI in HFpEF remains unclear, but prior reports and our
preliminary data suggest that impaired skeletal muscle energy metabolism may contribute. Previously, our group
demonstrated that HFpEF patients experience a rapid decrease in skeletal muscle high energy phosphates
(HEP) during exercise, as detected with non-invasive phosphorus magnetic resonance spectroscopy (31P MRS).
Other studies found that HFpEF patients have decreased skeletal muscle oxygen delivery and consumption
compared to controls. However, due to methodological limitations, it is unknown whether this is due to primary
impairments in mitochondrial oxidative metabolism, or whether HFpEF patients have attenuated peripheral blood
flow that secondarily limits mitochondrial oxygen utilization. With the need for better in vivo methods to answer
this important research question, we recently developed a novel interleaved MRS/MRI tool to simultaneously
measure muscle metabolism and peripheral blood flow. Moreover, new clinically available metabolic modulators
such as sodium-glucose cotransporter-2 inhibitors (SGLT2i) have been shown to improve clinical outcomes, but
their impact on muscle metabolism in HFpEF has not been studied or related to EI. Finally, conventional EI
measures during laboratory exercise testing fail to account for activities of daily living or sedentary behavior, but
these can now be measured with recent advancements in wearable health technology. However, the relationship
between these measures and skeletal muscle energetics have not been investigated in HFpEF patients.
Therefore, we will leverage our new MRS/MRI tool to test the central hypothesis that abnormalities in skeletal
muscle HEP metabolism are closely linked to manifestations of EI and fatigue in the daily lives of HFpEF patients
and can be attenuated with new metabolic modulators. The specific aims are: (1) optimize and refine our novel
interleaved MRS/MRI tool and investigate whether rapid HEP decline during exercise occurs despite preserved
blood flow in HFpEF patients, (2) explore whether metrics of activities of daily living are closely related to
conventional measures of EI and muscle metabolism in HFpEF, and (3) investigate whether SGLT2i
administration improves muscle metabolism and reduces EI in HFpEF. The combination of these three elements
will give the PI vital experience in developing clinical MRS/MRI research tools, evaluating wearable health device
data, and conducting a clinical longitudinal study that will generate crucial preliminary data for a future
randomized controlled trial using metabolic modulators. This Pathway to Independence award will be supported
by excellent career development resources at Johns Hopkins and mentorship from experts in MR, metabolism,
heart failure, wearable technology, and clinical trial design. The new tools and approaches will provide novel
insights into EI in HFpEF as well as transferable skills that the PI can leverage in his future research endeavors.

Public health relevance
Project Narrative Heart failure with preserved ejection fraction (HFpEF) is a growing clinical problem costing the US healthcare system >$30 billion annually by 2030, and characterized by severe exercise intolerance (EI), exertional fatigue, disability, and increased mortality. The proposed research will develop a new MRI-based tool to simultaneously measure skeletal muscle energy metabolism and blood flow, two potentially important contributors to EI in HFpEF, and utilize modern wearable health technology devices to assess EI during activities during daily living. These new tools will also be utilized to examine whether skeletal muscle energy metabolism, blood flow, and activities of daily living improve following administration of a metabolic modulator medicine (sodium-glucose cotransporter-2 inhibitors) in HFpEF patients, the results from which will provide new understanding and possible treatments to improve muscle metabolism and decrease disability in HFpEF patients.